Role of CB1R expressed in the prefrontal cortex in the control of locomotion

SUMMARY: Cannabis use in the US has alarmingly quadrupled in recent years: from 8.9% in 2016 to 17.5% in
2019 in individuals of age 12+ that used Cannabis in the last year. Thus, it is critical that we better understand
the bioactivity of ∆9-tetrahydrocannabinol (THC), the primary intoxicating compound in Cannabis. THC activates
cannabinoid receptors 1 (CB1R) and impairs several behaviors, including spontaneous locomotion. While it is
known that THC reduces spontaneous locomotion in mice, the neural-circuit basis and involvement of the
endocannabinoid (eCB), 2-arachidonoyl glycerol (2-AG), of this response remains largely unexplored. Using a
novel 2-AG sensor (eCB2.0) expressed in the prelimbic cortex (PrL) neurons, we discovered a tight correlation
between increase in 2-AG levels, calcium transients and initiation of spontaneous locomotion. Remarkably, both
2-AG and GCaMP6f calcium transients were significantly greater in THC-treated mice compared to vehicle-
treated mice, and the number of initiated locomotion events greatly reduced as a function of the hypolocomotion
response. Our hypothesis is that 2-AG activates CB1R’s on select PrL GABAergic interneuron subpopulations,
which disinhibits the glutamatergic activity within the PrL to control the initiation of spontaneous locomotion, and
THC potentiates this mechanism.
■ Aim 1 will determine how THC preferentially modulates the physiological activity of select GABAergic
subpopulations and glutamatergic neurons in the PrL. We will use RNAscope in situ hybridization to map CB1R
expression in GABAergic interneurons (GABA-IN’s) in the PrL. Combining GABA-IN-Cre lines with viral
techniques and channel-rhodopsin assisted circuit mapping with slice electrophysiology, we will determine how
2-AG’s action at CB1-R in PFC changes synaptic transmission and how this is impacted by THC.
■ Aim 2 will utilize in vivo fiber photometry and optogenetic manipulation of GABA-IN-Cre and VGLUT-Cre mice
expressing cre-dependent GCaMP6f or eCB2.0 in mouse PrL to record changes in neuronal activity and 2-AG
levels of inhibitory and excitatory neurons during spontaneous locomotion of mice treated with increasing doses
of THC. We will determine the specific 2-AG signaling components involved in this response using selective
pharmacological inhibitors. We will also virally express a CRISPR-CB1R construct to eliminate CB1R from GABA-
IN’s and glutamatergic neurons to establish the involvement of this target. Based on this premise, we will test
the hypothesis that select subpopulations of GABA-IN’s mediate changes in PrL activity associated with increase
in 2-AG levels and control of spontaneous locomotion. To determine the necessity and sufficiency of PrL activity
in THC treated mice, we will optogenetically stimulated or inhibited GABA-IN’s and glutamatergic neurons and
measured changes in spontaneous locomotion in vehicle and THC-treated mice.
This exploratory R21 grant proposal provides an ideal mechanisms and scientific foundation for studies aimed
at deciphering the mechanisms by which eCBs modulates PrL activity and how THC impairs locomotor behavior.

Public health relevance
PROJECT NARRATIVE As Cannabis use has doubled in the last 4 years, it is critical to better understand the behavioral impact of its primary intoxicating compound, ∆9-tetrahydrocannabinol (THC), in particular how it impairs spontaneous locomotion and how this relates to its abuse liability. Using a series of novel cutting-edge monitoring modalities, including an innovative sensor of the endocannabinoid, 2-arachidonoylglycerol (2-AG), we discovered that transient increase in 2-AG levels in the prelimbic cortex of the mouse brain correlates with initiation of locomotion after periods of immobility, and that this transient increase in 2-AG levels is potentiated by THC treatment. The goal of this exploratory R21 grant is to uncover the brain circuit mechanisms by which changes in 2-AG levels in the PFC are involved in initiation of locomotion and how THC modulate this mechanism in mice.